Structural and functional characterization of synaptic adhesion GPCR ADGRB3 binding interactions

ABSTRACT
Adhesion GPCRs (aGPCRs) represent a major class of GPCRs and are characterized by the presence of
extracellular adhesive regions and membrane proximal GAIN domains that are linked to typical GPCR 7TM
and cytoplasmic regions. aGPCRs have important roles including cell adhesion and migration, synaptogenesis
and immunity. Recent structural studies have yielded considerable insights into their activation at the level of
the 7TM and cytoplasmic regions, showing that insertion of a stachel peptide present in the stalk region into
the transmembrane domains drives conformational changes during activation. In contrast, adhesive
interactions of the membrane distal adhesive regions remain poorly characterized and, in particular, the
structural mechanisms by which these interactions cause release of the stachel sequence for activation are
unknown. This proposal aims to structurally characterize the adhesive interactions and activation mechanism
of ADGRB3, a member of an aGPCR family that is found at neuronal synapses and in heart muscle that is
critical for synaptogenesis, synaptic plasticity, synapse elimination and myoblast fusion. We will employ
structure-based approaches including cryo-EM structure determination of ADGRB3 and its adhesive
complexes complemented by functional assays to relate structural insights to receptor activation. Aim 1
focuses on the structure of the complete ADGRB3 ectodomain and its adhesive fragments using a combination
of structural approaches including cryo-EM, x-ray crystallography, and SAXS. Successful outcome of this aim
would provide insights into the organization of the ADGRB3 adhesive region and its coupling to the membrane
proximal activation regions. Aim 2 focuses on characterization of ADGRB3 adhesive binding interactions with
previously identified and candidate ligands using biophysical and in vitro binding assays to delineate binding
regions and complex compositions and stoichiometries. Structures of defined adhesive complexes will be
determined using cryo-EM and x-ray crystallography and complexes formed between lipid membranes will be
visualized by cryo-ET to examine their organization and assembly in a near-native state. Activation of
ADGRB3 by adhesive ligand binding will be assessed in functional assays and effects of mutations targeting
identified interfaces and key structural residues will be tested. Successful completion of this aim will provide
direct insights into ADGRB3 adhesion and activation of aGPCR signaling. Overall, the proposal aims to
provide fundamental mechanistic insights that could identify new targets for therapeutics.

Public health relevance
NARRATIVE Adhesion G-protein coupled receptors (aGPCRs) are involved in critical biological processes including cell adhesion and migration, synaptogenesis and immunity, and represent desirable drug targets. Recent advances have revealed details of their signaling mechanism but their adhesive binding interactions and how those interactions switch on signaling remain poorly understood. We aim to shed light on the adhesive properties of the ADGRB1-3 family of aGPCRs through structural approaches and binding interaction studies to identify new therapeutic targets.